Development of Non-Human Primate Models to Assess Immunological Mechanisms and Antigenic Targets of Protective Sporozoite (SPZ) Vaccines and Establish Superior Efficacy of Next Generation SPZ vaccines

ABSTRACT
Plasmodium falciparum (Pf) sporozoite (SPZ)-based vaccines have shown excellent safety and vaccine
efficacy (VE) in more than 25 clinical trials in Africa, Europe, and the US; Phase 3 assessment will begin in
mid-2020. Our goal during the next decade is to develop, license, and deploy next generation SPZ vaccines
with increased breadth, magnitude, and/or durability of VE and decreased cost of goods. Current assays and
animal models do not offer an alternative to clinical trials for demonstrating whether a vaccine candidate
exhibits superior performance to current SPZ vaccines. In this project we aim to develop in vitro assays and/or
non-human primate (NHP) models that indicate a vaccine recipient will be protected against Pf malaria by a
SPZ vaccine, and use them to show superiority of new SPZ vaccines. Success could come from increased
understanding of the 1) immunological effector mechanisms of protective immunity (PI), 2) antigenic targets of
PI, and/or 3) organs and cells involved in induction of the PI. Despite many studies, our understanding of these
3 areas has only modestly improved in the last 2 decades. In 2000 it was hypothesized that antigen-specific,
tissue resident CD8+ T cells in the liver that recognized Pf peptides bound to class I HLA molecules on the
surface of Pf-infected hepatocytes were the key cells mediating PI. This hypothesis led to a seminal study that
demonstrated subcutaneous administration of PfSPZ Vaccine did not lead to induction of PfSPZ-specific,
CD8+ T cells in the livers of immunized NHPs, but intravenous (IV) administration did. Based in large part on
these results, a clinical trial of IV administration was initiated, and the trial showed 100% VE. Subsequently,
>25 clinical trials of PfSPZ vaccines have shown that empirical alteration of PfSPZ/dose, number of doses,
interval between doses, and method of attenuation can improve performance of PfSPZ vaccines. However, we
have learned little about mechanisms and targets of PI, or the tissues involved in induction of PI. We believe
this is because the effector activity takes place in the liver, and induction of PI also takes place in the central
compartment, which is inaccessible in humans. Since our last major advance came from studying the livers of
immunized NHPs, we think much more information can be gleaned from this approach, including elucidation of
immunological effectors and targets, and comparison and down-selection of vaccine candidates. Therefore, in
this project we will develop 3 models in outbred NHPs to study SPZ vaccine-induced immunity, and use the
data generated in the models and systems biology assays to establish biomarkers and groups of assays
(signature) that consistently predict whether a NHP will be protected, and establish blood surrogates of tissue
markers. The best assays/ biomarkers/signatures will be assessed using serum, plasma, and PBMCs from
protected/unprotected subjects assessed in clinical trials of PfSPZ vaccines. Finally, we will use the
assays/biomarkers/signatures and model systems to screen newly developed SPZ vaccines, especially
genetically altered vaccines, to down-select which should move to process development and clinical testing.

Public health relevance
PROJECT NARRATIVE Malaria affects over two billion people, killing over 400,000 individuals each year mostly children in Africa. A powerful tool is needed for eliminating Plasmodium falciparum malaria from defined geographical areas. The ideal tool would be a highly effective, long-acting vaccine that prevents infection, and thereby disease and parasite transmission. There is currently no alternative to clinical trials for demonstrating that a vaccine candidate exhibits performance superior to current SPZ vaccines Therefore, in this project we will develop in vitro assays and/or non-human primate (NHP) models that indicate if a human will be protected against Pf infection by a SPZ vaccine, and use them to show superiority of new SPZ vaccines.